Signaling, Sensing, and Enzymatic Roles of Disordered Selenoproteins

PROJECT SUMMARY
Selenoproteins are prominently engaged in the integrated cellular response to stress. Here we focus on the ER-
bound membrane proteins selenoprotein K (selenok) and selenoprotein S (selenos), which are mostly known for
their connection to ER stress resolution. However, they also contribute to other cellular processes, such as
protein quality control, protein palmitoylation, cytokine secretion, immune response, calcium signaling, protein
trafficking, and differentiation. Consequently, their genetic variations are associated with heightened risks for -
among others- cardiovascular diseases, diabetes, and cancer, while their expression levels are tied to cancer
prognosis. However, there is no unifying and comprehensive view that plausibly spans their involvement in
multiple protein complexes and connects their seemingly disparate cellular roles.
Motivated by our work, we propose that selenok and selenos are putative ER-bound transcription factors. Upon
stimulation, they are processed and migrate to the nucleus to affect gene expression. To test selenok’s and
selenos’s direct involvement in gene transcription, we will determine their nuclear forms and evaluate their
interactions with nucleotides and transcription factors. We also suggest that in the ER membrane, selenok and
selenos contribute to protein quality control by acting as sensors of misfolded and misassembled proteins. There
are indications that the two selenoproteins act as accessory proteins of derlins, which are part of the ER-
associated degradation (ERAD) pore-forming complex. In this capacity, selenok and selenos could identify
“client” proteins for extraction through the ERAD’s pore, delivering them to derlins and thus preventing harmful
accumulation. Based on preliminary experiments, selenok and selenos appear able to recognize certain protein
surfaces, such as hydrophobic leucine zippers, positive patches on armadillo domains, and b-propeller folds of
proteins. These ‘recognition’ surfaces are usually hidden when proteins are properly folded, and complexes are
well-assembled. However, when these systems fail to take on their intended forms, these surfaces get exposed.
Using a structural biology approach, we will characterize the complex of selenok, selenos, and derlin. To
substantiate this sensing function, we will investigate how the presence and absence of selenos influence the
interactions between representative degradable ‘clients’ and derlins using in vivo photo-crosslinking of unnatural
amino acids at site-specific locations. In addition, we will study the interactome of the less characterized selenok
and identify its directly bound protein partners and enzymatic substrates.
These dual roles of selenok and selenos in gene transcription and ERAD sensing would explain how they can
influence numerous signaling pathways, engage with multiple protein complexes, and respond to cellular stress.
Altogether, this proposed research will provide fundamental insights into the rich diversity of selenium-based
redox biology and the specifics of cellular roles of selenok and selenos under normal and stressed conditions,
thus providing a molecular-level explanation of why they exert such a significant influence on human health.

Public health relevance
PROJECT NARRATIVE Selenoprotein K and selenoprotein S are related enzymes that use selenium to mitigate cellular stress. Understanding in detail their functions not only enhances our knowledge of how cells utilize selenium for protection but also uncovers the molecular reasons why the dysfunction of these proteins can lead to illnesses such as cancer, type 2 diabetes, and cardiovascular diseases.